Mitigating Ischemia-Reperfusion Injury to Reduce Early Damage to Intestinal Allografts

PROJECT SUMMARY
Intestinal failure results from conditions such as trauma-related small bowel injury, necrotizing enterocolitis, and
inflammatory bowel disease. Treatment options are limited; however, an important emerging therapeutic
approach is intestinal transplantation (IT). When successful, IT is associated with marked improvements in
quality of life and overall well-being. However, its current success rate is <60% 5 years post-transplant, and there
are multiple factors that limit its clinical use. The major impedance to more successful transplants is donor
tissues' limited tolerance to current storage methods. The current standard, static cold storage (CS), has been
shown to cause epithelial damage after 6 hours (hr) as well as inflammation and loss of epithelial tight junctions.
Indeed, clinical studies show that intestinal allograft preservation of >6 hr of cold ischemic time correlates with a
progressively higher rate of recipient post-reperfusion syndrome, translocation of enteric bacteria that cause
systemic infections, induction of inflammation, and increased transplant failure. Thus, methods that could
improve graft viability and organ preservation, especially reducing the incidence and severity of ischemia-
reperfusion injury could have a major impact on enhancing the IT success rate, making it the preferred therapy
for intestinal failure patients. Normothermic machine perfusion (NMP) has shown promise in clinical heart, lung,
and liver transplant scenarios, but this potentially groundbreaking advancement has not been developed for
intestinal failure. We have performed highly promising preliminary studies using NMP in porcine and human
intestine and have shown compared to CS: 1) Successful allogeneic transplantation with fewer histologic signs
of epithelial reperfusion injury, enhanced intestinal stem cell activation, and histologic evidence of active
epithelial restitution and regeneration in 6 hr NMP-stored porcine small intestine. 2) Histologically intact epithelial
barrier in 6 hr NMP-stored human donor small intestine. We hypothesize that intestinal NMP will reduce
ischemia-reperfusion injury by enhancing epithelial barrier integrity and function and decreasing inflammation,
thereby minimizing factors that prime the graft for failure. We will use an ex vivo pig intestinal tissue and a porcine
model of IT to address the hypothesis with the following specific aims: Aim 1. To determine the extent to which
NMP protects epithelial cell integrity and regenerative potential to enhance barrier function. Aim 2. To determine
if NMP minimizes allograft inflammatory activation and the cellular mechanisms mediating pro- and anti-
inflammatory processes during allograft storage. Aim 3. To determine if NMP enhances the suitability of injured
intestine for transplantation. Successful completion of these aims will develop a mechanistic basis to enhance
intestinal allograft function by mitigating preservation injury and will address the practical limiting factor of the
number of grafts suitable for transplant. This could dramatically expand the applicability of IT to patients with
intestinal failure and lead to an enhanced quality of life for these individuals.

Public health relevance
This project seeks to improve both graft preservation and transplant outcomes, to expand the feasibility of transplantation as a treatment for intestinal failure patients. The team will advance donor organ preservation strategies that limit ischemia reperfusion injury and enhance our understanding of the complex interactions between graft immune factors and epithelial barrier integrity. This research will also apply novel technologic platforms to evaluate intestinal viability and barrier function in real-time.